Regulators of the Erythroid Terminal Differentiation Decision and their Connection to the Cell Cycle

? DESCRIPTION (provided by applicant): BFUe, the most primitive committed erythroid progenitors, are capable of extensive proliferation. BFUe differentiate into CFUe, cells with very restricted proliferative potential. Pu.1 is a hematopoietic, master regulatory ETS transcription factor (TF) that is required for BFUe self-renewal. PU.1 inhibits BFUe differentiation. Down regulation of PU.1 occurs and is required for BFUe to differentiate into CFUe. Despite Pu.1's central role in regulating the terminal differentiation decision, the molecular mechanism controlling Pu.1's expression and down-regulation are not known. We propose to identify the cis-regulatory elements that control Pu.1 expression in BFUe and it's down regulation as these progenitors enter terminal differentiation. Using computational analysis of gene expression, ChIP Seq and other types of genome-wide data sets, we have identified several DNA binding proteins as candidates for controlling Pu.1 expression in BFUe, including SATB1, E2F4, Runx and Jun. The analysis also suggests that some of these factors, Runx and Jun, collaborate with Pu.1 to regulate a large set of genes that promote proliferation of BFUe and antagonize their terminal differentiation. We propose to determine whether these factors regulate Pu.1 expression. We also propose to determine whether they work in concert with Pu.1 to control a set of important gene targets in erythroid cells. The successful completion of this work will provide essential insights into the transcriptional networks that regulate red blood cell output.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to determine the molecular mechanisms controlling the terminal differentiation decision in erythroid progenitors; Pu.1, an ETS family transcription factor, is central to this decision but the precise mechanism of Pu.1 regulation is not known. We will use reporter assays, manipulations of gene expression, and computational approaches to uncover Pu.1 regulation and its broader transcriptional network in erythroid progenitors. A clear molecular model of the terminal differentiation decision is the next step in understanding normal erythropoiesis and generating clinical targets that will be useful in correcting defects in red blood cell output such as anemia.